Synergistic Mechanisms of chronic Innate Immune Activation in Microglia by Opiates and HIV Infection

ABSTRACT
Persistent immune activation is the defining feature of HIV-1 infection in vivo and a driver of progression to end-
stage AIDS. Systemic immune activation in people living with HIV has been hypothesized to account for higher
incidence of chronic inflammatory diseases, including HIV-associated neurocognitive disorders (HAND).
Importantly, numerous studies have demonstrated that populations living with opioid-use disorder (OUD) have
a higher occurrence of comorbid HIV infection, suggesting both potential socio-economic and neurocognitive
influence. This comorbidity of OUD and HIV has also been shown to increase neuroinflammation and exacerbate
the progression of HIV infection and HAND. While some studies have investigated the interactive effects of OUD
and HAND in few cell types in isolation, the molecular mechanisms linking the two conditions is still largely
unknown, especially in primary human microglia, neurons and astrocytes. Hence, we believe that this proposal
fulfills a critical unmet need by establishing primary human neuronal cell cultures and an unbiased, systematic
single cell transcriptomic survey of these cultures in the context of co-exposure of opiates and HIV-1 infection.
In this proposal, we will establish 3D spheroid cultures consisting of induced pluripotent stem cell (iPSC)-derived
human microglia, astrocytes and neurons, derived from 10 independent donor lines established at BUMC, that
will recapitulate spatial complexity of cell-to-cell interactions in the brain, and interrogate the effect of HIV
infection and morphine exposure on persistent innate immune activation. We will utilize cutting-edge single cell
transcriptomics analysis to identify the microglia-intrinsic pathway that promotes induction of pro-inflammatory
responses upon co-exposure to HIV and opiates and the neurodegenerative pathways contributing to neuronal
cell injury. Finally, information from these transcriptomic studies will be leveraged to inform CRISPR/Cas-based
knock-out strategies to selectively delete key pathways in iPSC-microglia to alleviate neuroinflammation. We
believe that results from these studies will inform future therapeutic development to prevent HIV and opiate-
induced neuroinflammation and prevent development of HAND in HIV+ substance use population.

Public health relevance
PROJECT NARRATIVE Continued opioid abuse and HIV infection contribute to exacerbated systemic and CNS inflammation. The proposed project aims to define molecular mechanisms of opiate and HIV-induced microglia activation and neuronal damage utilizing 3D spheroid cultures utilizing iPSC-derived primary human neuronal cells. These in vitro model systems will be leveraged to identify host pathways to prevent microgliosis and the resulting neuroinflammation, which are critical to preventing the neuropathogenesis of HIV.